Reactivating p53 Function with a Novel Structure-based Peptide as a Therapeutic Approach for Overcoming Platinum Resistance

Treatments that restore p53 activity could provide a breakthrough in cancer therapy given that p53 is mutated in
many cancers. Successful targeting of p53 is an unmet clinical need evidenced by the lack of FDA-approved
drugs in this category. We have collaboratively developed and tested ReACp53, a peptide that re-enables p53
function by preventing its aggregation. Our previous work demonstrated the efficacy of ReACp53 monotherapy
in targeting high-grade serous ovarian cancers (HGSOCs), which are tumors characterized by loss of p53
function. HGSOCs are deadly gynecologic malignancies that claim the lives of 14,000 U.S. women annually
despite radical surgeries and administration of carboplatin standard chemotherapy. We hypothesize that
ReACp53 can sensitize platinum-resistant HGSOCs to carboplatin. This combination therapy may prevent and
target recurrence of this aggressive cancer.
Building on our previous work, we propose the following aims that will facilitate clinical translation of our
therapeutic: (1) Determine if platinum-resistant ovarian cancer cells can be sensitized to carboplatin when treated
with ReACp53. A novel in vitro 3D miniring organoid drug assay will be used to test the sensitivity of 72 primary
HGSOCs in this aim. Subaim 1.1 will focus on testing this therapy in targeting newly-diagnosed HGSOCs
enriched for platinum-resistant cells following exposure to neoadjuvant carboplatin. This response will be
compared to matched pre-therapy tumor specimens from the same patient. In Subaim 1.2 we will test the
efficacy of this combination in targeting recurrent platinum-resistant HGSOCs. p53 mutation status in all
specimens will be correlated with drug response. Results will demonstrate if this therapeutic approach can be
efficacious in targeting platinum-resistant HGSOCs. (2) Determine the effect of p53 mutations on modulating
ReACp53 and carboplatin response using in vitro and in vivo tumor models. Here, we will take a genetic approach
by engineering platinum-resistant p53-null ovarian tumor cells to express known and common p53 mutations
reported in HGSOCs. Response of these tumor cells to combination therapy will be tested in vitro in Subaim 2.1
and in vivo in Subaim 2.2. Results will demonstrate if the addition of ReACp53 to carboplatin can potentiate cell
death in platinum-resistant ovarian cancer cells expressing common p53 mutations found in up to 30% of all
HGSOCs. (3) Test the efficacy of ReACp53 and carboplatin combination therapy in targeting platinum-resistant
HGSOC PDXs. p53 mutations are highly implicated in mediating platinum resistance in many carcinomas. Here,
we will test if the addition of ReACp53 to carboplatin can restore platinum sensitivity of recurrent human HGSOCs
using PDX models. In Subaim 3.1 PDXs will be established from platinum resistant HGSOCs, 3 sensitive and 3
resistant to combination therapy based on in vitro drug testing. In Subaim 3.2, mice bearing PDXs will be treated
with vehicle, ReACp53, carboplatin, or the combination therapy. In vivo tumor response will be correlated with
(a) in vitro drug sensitivity and (b) p53 mutation status. Findings may provide the rationale and tools for selecting
tumors that may benefit from this therapeutic approach in future clinical trials.
Collectively, by restoring p53 function and defining biomarkers of response to this therapy, we may be able to
define a new and more effective precision medicine therapeutic approach for Veteran patients diagnosed with
p53-driven ovarian cancers. The potential impact of our work is broad and may extend beyond female Veterans
as this therapy can be applicable to the 20,000 female and male Veterans diagnosed with aggressive p53-
mutated tumors each year.

Public health relevance
p53 is a protein that regulates gene stability and is mutated in a large number of ovarian cancers. Ovarian cancers are initially sensitive to carboplatin chemotherapy but recur with resistant disease. p53 mutations play a major role in causing chemotherapy resistance. We have tested the therapeutic efficacy of a peptide, ReACp53, which can refunctionalize p53 in a subset of ovarian cancers. Here, we will test if treatment with ReACp53 can restore sensitivity to carboplatin. A newly-developed disease-in-a-dish tumor model alongside in vivo mouse models will be used to test response of a large number of tumors from women Veterans impacted by ovarian cancer. Results of this proposal will lay the groundwork for clinical trials that can validate the efficacy of this combination therapy and the potential of the disease-in-a-dish model as a companion diagnostic test in selecting patients who may benefit from this treatment. p53 is mutated in up to 50% of all human tumors, many of which are treated with carboplatin. Thus, our findings may have broad applicability to many other cancers.